Testing the cellular mechanisms that underlie cerebellar synaptic plasticity and motor learning

Abstract
The cerebellum is a compelling model for studying how cellular activity can shape animal behavior, one of the
key goals of neuroscience research. Molecular, circuit, and behavioral studies have tested cerebellar function at
these respective levels; however, due to technical limitations for measuring synaptic responses in vivo, it has
been challenging to connect synaptic plasticity mechanisms with cerebellum-dependent motor learning. This
proposal is designed to test the role of synaptic plasticity onto cerebellar Purkinje cells in motor learning, using
cerebellar-dependent delay eyelid conditioning behavior to assess plasticity mechanisms at the parallel fiber-
Purkinje cell synapse, as well as the molecular signaling cascades involved in the expression of this form of
plasticity. Thus, these experiments will directly test the hypothesis that long-term synaptic depression of parallel
fiber inputs onto Purkinje cells is involved in cerebellar motor learning. I will use a powerful combination of
established optogenetic and in vitro electrophysiology techniques to measure synaptic plasticity in tissue from
animals trained on the delay eyelid conditioning task. Additionally, I will test a novel biosensor, SPOTlight, for its
potential to identify Purkinje cells that have undergone postsynaptic long-term depression. Overall, this research
will test a learning mechanism at the molecular, circuit, and behavioral levels to address a foundational question
of how cerebellar function enables learning.

Public health relevance
Project Narrative Decades of work in the cerebellar field have defined sensorimotor pathways required for motor learning, characterized forms of plasticity at various synapses in the cerebellar circuit, identified molecular signaling cascades involved in synaptic plasticity, and generated theoretical frameworks for how specific sites of synaptic plasticity could enable motor learning. Despite these advances, technical limitations for measuring synaptic responses in vivo have frustrated attempts to provide an overarching connection between synaptic plasticity mechanisms within the cerebellar circuit and cerebellar motor learning. I will use a powerful combination of cerebellar-dependent behavior, electrophysiology, and a novel biosensor technology to bridge molecular, circuit, and behavioral approaches and test the role of Purkinje cell long-term depression in cerebellar motor learning.